Product Evaluation and Manipulation Core (PEMC)

PROJECT SUMMARY – PRODUCT EVALUATION AND MANIPULATION CORE
The goal of the Product Evaluation and Manipulation Core (PEMC) is to support and complement the human
research conducted in the Projects (P1-P4) and pilot studies needed to inform the evidence base surrounding
how the three nicotine dimensions (concentration, form, and isomer) affect tobacco product appeal,
addictiveness, and toxicity. Our Center focuses on novel tobacco products that have a credible potential for harm
reduction in established cigarette smokers or smokeless tobacco users. However, there are significant data gaps
regarding key product characteristics and appeal to nonusers, which is concerning given their high prevalence
of use and recent rapid increase in sales. The PEMC will generate product characterization data, which, in
concert with P1-P4 results, will accomplish our Center’s objective: provide the evidence needed to clarify a
pathway for meaningful harm reduction in established tobacco product use, while limiting the appeal of novel
tobacco products for youth and adult never smokers. A firm understanding of tobacco product design
characteristics, including chemical, physical, and bacterial properties, is central to the Industry’s Consumer
Response Model. Therefore, the PEMC plays a critical role in our Center’s theme “Flipping the Script”: Using
the Industry’s Nicotine Playbook to Maximize Public Health, as we endeavor to generate the data needed
to fuel regulatory policies that maximize public health and not industry sales. The PEMC specific aims are to 1)
Precisely manipulate the three nicotine dimensions in EC liquids to evaluate their effect on human behaviors,
mainstream emissions, and cellular toxicity; and 2) Employ an array of physicochemical analytical methods to
quantify nicotine dimensions, other ingredients, and contaminants, in tobacco products, and 3) harmful and
potentially harmful constituents and other toxicants in their emissions. The PEMC will be led by Prof. Marielle
Brinkman and Dr. Ahmad El Hellani, who have extensive experience manipulating and characterizing tobacco
products to inform tobacco regulation in both Tobacco Regulatory Science Center and standalone grants. The
OSU-TCORS PEMC proposes a varied set of physicochemical analytical capabilities, a successful track record
in the manipulation of tobacco products to inform regulation, and a strong emphasis on qualifying all
measurements with a robust quality control program.

Public health relevance
The tobacco industry has historically manipulated nicotine in its products to increase their appeal and potential for addiction for the widest possible audience, including young people and non-users. They are now doing this with newer products, like e-cigarettes and oral nicotine pouches. Our center will study how these manipulations affect young people and adults, with the goal of helping the FDA develop regulations that will make these products less appealing to young people, including non-users, but not older adult smokers and smokeless tobacco users who may benefit from their use.